Examining the association between psychosocial factors and adherence to a home exercise program for upper extremity recovery in Veteran stroke survivors

The proposed VA Career Development Award (CDA-1) is designed to provide support and mentorship for the
PI, Dr. Gabrielle Scronce, to become a successful, independent VA investigator improving the lives of Veteran
stroke survivors. Dr. Scronce obtained her Doctor of Physical Therapy and PhD in Human Movement Science
at the University of North Carolina at Chapel Hill. She is currently a WOC researcher at the Ralph H. Johnson
VAMC and a postdoctoral scholar at the Medical University of South Carolina under the primary mentorship of
Dr. Na Jin Seo. The PI’s career and research training goals are influenced by her experience as a physical
therapist working with Veterans and active duty service members, as these interactions have allowed her to
appreciate the unique strengths and needs of these individuals that are insufficiently understood and addressed
by standard physical therapy practice. Specifically, her training goals are to develop the foundation for
psychosocial factors and behavioral interventions to improve Veterans’ adherence to home exercise programs
(HEP), enhance skills in quantitative, qualitative, and mixed-methods research, develop proficiency in clinical
trial design and management for stroke rehabilitation, and advance her professional development through
grantsmanship, publications, scientific presentations, mentorship, and community engagement. The
interprofessional team of mentors in this CDA-1 is well-suited to guide the PI as she works towards achieving
her training goals. This CDA-1 adds new mentorship to Dr. Scronce from Dr. Lisa McTeague in psychosocial
factors/measures and behavioral interventions, from Dr. Jillian Harvey in qualitative and mixed methods
research, and from Dr. Viswanathan Ramakrishnan in quantitative research. In this CDA-1, Dr. Scronce will
continue to receive mentorship from Dr. Seo with the addition of training in objective accelerometry to track HEP
adherence. The study Dr. Scronce has proposed in this CDA-1 addresses the important problem of inadequate
adherence to upper extremity (UE) HEP among stroke survivors, a problem that limits recovery and survivors’
subsequent ability to participate in desired activities. The objective of this study is to explain how modifiable
psychosocial factors manifest themselves in terms of barriers and facilitators for HEP adherence among Veteran
stroke survivors. This objective will be met through an observational study with mixed-methods design in which
Veterans with UE impairment after stroke will be asked to complete objective measures of modifiable
psychosocial factors, complete a HEP for 7 days during which adherence will be objectively monitored, and
participate in semi-structured interviews to share barriers and facilitators to HEP adherence. Quantitative findings
relating psychosocial factors with HEP adherence and qualitative findings from the semi-structured interview will
be integrated to elucidate the relationship among psychosocial factors, barriers and facilitators for HEP
adherence, and objective HEP adherence level. The long-term goal is to use the results of this study to develop
a new enhanced behavioral intervention that can be delivered within a rehabilitation visit and that targets
individual Veterans’ psychosocial factors to increase adherence to HEP, ultimately improving UE recovery in
Veteran stroke survivors.

Public health relevance
Research suggests that extensive repetitions of upper extremity (UE) activity can improve UE recovery post- stroke. A home exercise program (HEP) is commonly prescribed as part of rehabilitation therapy to facilitate greater repetitions of UE activity. Unfortunately, patient adherence to HEP is often low, limiting overall recovery. Behavioral interventions may be helpful in improving adherence, but there is no evidence of the effects of such interventions in stroke rehabilitation for Veterans. There is a need to understand the relationships among Veteran stroke survivors’ psychosocial factors, barriers and facilitators to HEP adherence, and objective HEP adherence. This is a necessary first step toward future development of a behavioral intervention that adequately addresses barriers and facilitators related to psychosocial factors to increase HEP adherence and promote recovery for Veterans with stroke.